Gatekeepers of Mitochondrial NAD+

Project summary We are working on new in vivo methods to study the intermediary metabolite nicotinamide adenine dinucleotide (NAD+). NAD+ is critical for cellular metabolism and health, and its decreased steady-state levels have been linked to human pathologies such as neurodegeneration, cardiovascular disease, metabolic syndrome, and cancer. NAD+ concentrations are highly compartmentalized by cell type, subcellular localization, and its protein- bound or free fractions. A lack of methods that can monitor free NAD+ in cells with spatial and temporal information has hindered our learning about the relevant pools, threshold concentrations, and fluctuations that NAD+ may undergo leading to disease onset. This precludes our ability to identify treatments or approaches to intervene before NAD+ levels are misregulated. In particular, there are no genetically-encoded methods for in vivo mitochondrial NAD+ measurements. Free mitochondrial NAD+ is required for cellular respiration, and diminished levels due to genetics, age, or infection can promote reductive metabolism. Thus, to address this gap we will improve the brightness (Aim 1) of a variant of the current NAD+ sensor, which is able to monitor free mitochondrial NAD+ in cells. We will also generate a series of constructs that will be used to test a new approach for improving the dynamic range of fluorescent readout (Aim 2). Together, data from these the aims will identify a feasible method to robustly obtain free mitochondrial NAD+ measurements in vivo.

Public health relevance
Project Narrative Decreased free mitochondrial NAD+ levels would limit cellular respiration and can promote pathology due to metabolic disequilibrium. Currently, there is no technology to study how this mechanism contributes to homeostasis or disease because we cannot measure free mitochondrial NAD+ in vivo. We are developing new genetically-encoded sensor systems to directly address this gap.